Development of a novel rodent model of hypothalamic hamartoma and epilepsy

ABSTRACT: Hypothalamic Hamartomas (HH) are noncancerous growths of disorganized cells and are believed to result as a consequence of somatic mutations in sonic hedgehog (SHH) pathway genes during embryonic development. HH are associated with gelastic seizures (GS) that are difficult to control with existing anti-seizure drugs, and people with HH also go on to develop even more severe pharmacoresistant seizure types due to secondary epileptogenesis. Thus, there is a significant clinical need to develop new therapies to treat the debilitating pharmacoresistant seizures that result as a direct consequence of HH and/or that develop following secondary epileptogenesis. A complete absence of animal models that recapitulate the phenotypes resulting from HH is a significant reason why discovery and development of novel pharmacological treatments has been hindered. The present R21 proposal seeks to solve this problem by generating a novel mouse model of HH for use in therapy discovery. This goal will be accomplished by utilizing tamoxifen-inducible Cre-Lox recombination to independently express and test two etiologically relevant somatic mutations in SHH signaling molecules during periods of peak hypothalamic cellular proliferation and examine resultant hypothalamic anatomy, gene expression, and physiology in these mice. Since activation of SHH signaling is known to promote cell proliferation, Aim 1 will independently examine the effects of expressing SmoM2 (a constitutively activated form of the Smoothened GPCR) that will produce a cell autonomous upregulation of SHH signaling in a mosaic of affected cells in the developing hypothalamus. Aim 2 will independently examine the effects of expressing a truncated version of the SHH pathway transcription factor GLI3 (GLI3T) that has been shown in resected HH tissues. Expression of GLI3T acts as a constitutive repressor and is expected to downregulate SHH signaling. Downregulation of SHH signaling in a limited number of cells may not conflict with our hypothesis that an overall upregulation of SHH signaling is responsible for the development of HH because, as it has recently been demonstrated, a loss of SHH signaling in a mosaic of developing hypothalamic cells can cause a cell non- autonomous upregulation of SHH signaling in neighboring wild-type cells. Therefore, this R21 proposal will utilize existing mouse lines to directly test the hypothesis that development of HH and consequent seizure phenotypes can result from somatic mutations that produce either a cell autonomous or non-autonomous upregulation in SHH signaling during hypothalamic development. Thus, this work has the potential to provide the field with the first animal model of HH and sets the stage for future work to determine novel therapeutic approaches for the treatment of refractory seizures and to examine the mechanisms underlying secondary epileptogenesis.

Public health relevance
NARRATIVE: This work will tackle a serious limitation in the field of epilepsy research by developing a novel rodent model of hypothalamic hamartoma. Seizures that occur as a consequence of hypothalamic hamartomas are resistant to existing anti-seizure drugs, and hypothalamic hamartomas represent a significant source of subcortical secondary epileptogenesis. Therefore, the rodent models that this proposal aims to generate will provide the research community with an unprecedented opportunity to begin the search for novel therapies for the treatment resistant seizures and epileptogenesis occurring in people with hypothalamic hamartoma and related epilepsies.